A Prospective Observational Cohort Study to Evaluate and Predict Oropharyngeal Dysphagia (OD) Improvement in Hospitalized Patients with Alzheimer's disease and related Dementias (AD/ADRD)

Project Abstract. Oropharyngeal dysphagia (OD) is highly prevalent (up to 86%) in hospitalized patients with
Alzheimer’s disease (AD) and AD-related dementias (AD/ADRD), because baseline factors (e.g., age,
functional status) are exacerbated by acute factors (e.g., acute illness, delirium). Although acute factors often
improve or even resolve prior to hospital discharge, no standard of care exists for reassessment prior to
discharge. Further, dysphagia diets, the mainstay hospital management of OD, are frequently continued
without reassessment when patients transition back to the community or long-term care. This is concerning
because dysphagia diets, also lead to malnutrition, dehydration, and reduced quality of life (QoL). In our pilot
prospective observational study of hospitalized patients with AD/ADRD and OD (N=62), only 25.8% (n=16) had
OD reassessment prior to discharge, yet, of those reassessed, 62.5% (n=10) had clinical OD improvement,
resulting in diet liberalization. However, it is not possible to reassess every patient in the real-world setting.
Thus, developing a machine-learning (ML) model that predicts which patients with AD/ADRD are likely to have
improvement is a critical and innovative first step to develop a cost-effective targeted approach to OD
reassessment (Aim 1). Further, previous research used physiologic swallow measures to assess OD recovery
and treatment response (e.g., swallow rehabilitation), without examining associations with clinical OD
improvement, namely diet liberalization. This will be the first AD/ADRD study to prospectively evaluate OD
improvement using a reference standard test (modified barium swallow study, MBSS) to determine
associations between physiologic swallow improvement and clinical OD improvement (Aim 2). Our
interdisciplinary team with expertise in geriatrics, hospital medicine, AD/ADRD and OD research, biostatistics,
and ML methods is well-poised to complete this research. Study design: We will prospectively recruit (N=336)
hospitalized patients with AD/ADRD and a diagnosis of OD on a reference standard assessment (MBSS). All
patients will undergo a MBSS at initial assessment and again, prior to hospital discharge (reassessment).
Specific aims: we propose to conduct a prospective observational cohort study of hospitalized patients with
AD/ADRD, diagnosed with OD, to: Aim 1a) develop a ML model to predict which patients will have clinical OD
improvement prior to hospital discharge; Aim 1b) prospectively, silently validate the model to acquire real-time
preliminary performance metrics, in preparation for a full-scale prospective validation; and Aim 2) determine
the association between improvement in physiologic swallow impairment and clinical OD improvement.
Impact: Our findings will: 1) inform OD reassessment prior to hospital discharge, to reduce unnecessary use of
dysphagia diets and improve outcomes (e.g., QoL) for persons with AD/ADRD; and 2) advance OD research
by associating physiologic swallow impairment with clinical OD improvement (i.e., diet liberalization), which will
strengthen clinical significance for studies evaluating OD recovery and treatment.

Public health relevance
Project Narrative Oropharyngeal Dysphagia (OD) is a common syndrome that affects up to 84% of hospitalized older adults with Alzheimer’s disease (AD) and AD-related dementias (AD/ADRD). Despite the potential for clinical OD improvement, no standard of care exists for OD reassessment prior to hospital discharge. Developing a machine-learning model that predicts which patients with AD/ADRD are likely to have OD improvement, is critical for reducing unnecessary use of restrictive diets and improving quality of life for this vulnerable population.